STRUCTURE-FUNCTION STUDY OF GROWTH FACTOR--GASTRIN RELEASING POLYPEPTIDE

Gastrin releasing polypeptide (GRP) has been shown to be an autocrine facto for small cell lung carcinoma (SCLC) cells both in vivo and in vitro. This polypeptide has a high degree of sequence homology with the carboxy termina domain of bombesin (BN). Both GRP and BN are synthesized as larger precurso molecules. In order for the pro-molecule to become bioactive, further enzymatic processing is required, i.e. , truncation as well as the formatio of a C-terminal amide. The latter requires the presence of an amidating enzyme. As a first step toward designing a potential antagonist for the growth of SCLC cells, we examined the requirements for the ligand binding to the BN receptor by synthesizing a series of C-terminal domain analogues of BN. Contrary to previous reports, we found that the precursor itself is a very weak agonist. Furthermore, based on our BN receptor binding data, th mode of BN receptor binding does not occur by an end-on approach but rather side-on. Further work on the isolation and characterization of GRP amidatin enzyme from several established SCLC lines is ongoing.